Mechanisms of NAT2 Regulation of Insulin Resistance and Mitochondrial Dysfunction

PROJECT SUMMARY/ABSTRACT
Decreased insulin sensitivity (insulin resistance, IR) is a fundamental abnormality in patients with type 2
diabetes (T2D), and a major risk factor for cardiovascular disease (CVD). We led a genome wide association
study (GWAS) for direct measures of IR and identified a novel IR gene, N-acetyl transferase 2 (NAT2). Non-
synonymous coding variants in NAT2 were associated with increased IR independently of body mass index as
well as IR-related traits. Knockdown and overexpression of the mouse ortholog Nat1 led to changes in glucose
homeostasis in adipocytes and myoblasts. Nat1 deficient mice (Nat1 KO) had decreased insulin sensitivity and
elevations in fasting blood glucose, insulin and triglycerides. Nat1 is highly co-regulated with key mitochondrial
genes and RNA-interference mediated silencing of Nat1 leads to mitochondrial dysfunction characterized by
increased intracellular reactive oxygen species and mitochondrial fragmentation as well as decreased
mitochondrial membrane potential, biogenesis, mass, cellular respiration and ATP generation. Nat1 KO mice
have a decrease in basal metabolic rate and exercise capacity without altered thermogenesis versus Nat1 wild
type (Nat1 WT) mice. Nat1 KO mice also have changes in plasma metabolites and lipids, such as decreased
levels of acylcarnitines, and indirect calorimetry data shows decreased utilization of fats for energy, suggesting
that Nat1 deficiency is associated with an impaired fatty acid oxidation (FAO). New data indicate that
supernatant from Nat1 deficient liver cells results in IR in adipocytes. Our overall hypothesis is that Nat1
binds to and regulates key mediators of mitochondrial function and energy balance in the liver ultimately
leading to IR. Using our unique resources including a liver specific knockout mouse (Nat1 LKO), we will test
this hypothesis and elucidate the mechanisms of insulin resistance caused by Nat1 deficiency. Nat1 is known
to acetylate certain drugs and carcinogens but the endogenous substrate/s are unknown. Studies in Aim 1 will
identify Nat1 protein-protein interactions and Nat1 acetylation substrates that regulate energy balance and
metabolism. Our hypothesis is that Nat1 binds key regulators of mitochondrial function. In Aim 2 we will define
the specific mitochondrial defects in Nat1 deficiency. Our hypothesis is that Nat1 deficiency causes impaired
FAO and that this can be rescued by augmenting β-oxidation. In Aim 3 we will define mediators of local and
systemic effects of Nat1 deficiency. Nat1 is highly expressed in the liver with more modest expression in
insulin-sensitive tissues. We believe that hepatic Nat1 mediates whole body insulin sensitivity specifically
through signaling intermediates that act through effects on adipose and skeletal muscle. We will confirm this
through detailed phenotyping, including euglycemic clamp, of liver specific Nat1 KO. We will also identify
secreted factors that impair insulin sensitivity in Nat1 deficiency building on our co-culture data from Nat1
deficient liver cells and adipocytes. These aims will define the pathophysiological role of the novel IR gene
Nat1, thereby increasing our understanding of IR, which is a necessary step towards new therapies.

Public health relevance
PROJECT NARRATIVE Decreased insulin sensitivity (insulin resistance) is a fundamental abnormality in patients with type 2 diabetes, and a major risk factor for cardiovascular disease. We recently identified a novel human IR gene NAT2 (mouse ortholog Nat1) and showed that Nat1 deficiency not only causes insulin resistance but also results in profound mitochondrial function in cells and in mice. In this grant we will pursue in vitro and in vivo mechanistic studies to define the mechanistic link between Nat1, insulin resistance and mitochondrial dysfunction, which is crucial to understanding the pathogenesis of insulin resistance and developing novel therapeutics.